Dopaminergic regulation of dendritic spine function and plasticity in prefrontal cortex

Project Summary/Abstract
Perturbation of spine function or development produces profound behavioral and cognitive dysfunction and
remains a critical component to neurodevelopmental and neurodegenerative synaptopathies such as
schizophrenia. While dendritic spines mediate glutamatergic signaling, recent evidence suggests that dopamine
modulates dendritic spine plasticity in in vitro reduced model systems. The central goal of this project is to identify
the role of dopamine on dendritic spine plasticity in vivo. My main hypothesis is that local dopaminergic signaling
mediates the emergence, function, and pruning of dendritic spines. In Aim-1 I will use holographic imaging of
functional responses of dendritic spines to synaptic inputs in vivo. In Aim-2, I will use holographic optogenetic
stimulation of dopaminergic neuron terminals and caged dopamine to investigate the control of dendritic spine
voltage dynamics via dopaminergic signaling. Finally, in Aim-3 I will perform experiments using both glutamate
and dopaminergic signaling to study their roles in dendritic spine dynamics in mouse models of schizophrenia. I
will use voltage imaging with a novel genetically encoded voltage indicator targeted to dendritic spines (spASAP).
To measure the structural (morphological differences) and functional (voltage fluctuation) responses of spines, I
will perform these aims in layer 5 of prelimbic area of mouse prefrontal cortex, an area where dopaminergic
neurons project and implicated in schizophrenia, as well one that exhibits dysregulation of spine number and
morphology distribution but without significant functional characterization. My proposed studies will greatly
expand the understanding how relationships to voltage fluctuations are altered by key mechanisms related to
dopaminergic modulation of dendritic spine plasticity, and how dendritic spine plasticity are dysregulated in
diseases such as schizophrenia.

Public health relevance
Project Narrative Perturbation of spine function or development produces profound behavioral and cognitive dysfunction and remains a critical component to neurodevelopmental and neurodegenerative synaptopathies such as schizophrenia. The central goal of this project is to test the hypothesis that dopamine contributes to dendritic spine plasticity in vivo and is altered in mouse models of schizophrenia. This project is relevant to the mission of the National Institute of Mental Health (NIMH) is to transform the understanding and treatment of mental illnesses through basic and clinical research, paving the way for prevention, recovery, and cure.